Healthy Brain and Child Development National Consortium Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
Opioid use during pregnancy is widespread and associated with adverse outcomes for the pregnant individual
and the developing child. Prenatal opioid exposure is associated with a wide range of negative fetal and child
outcomes, including reduced fetal growth, premature birth, lower birthweight, congenital defects, increased
neonatal healthcare, and heightened risk for later behavioral (e.g., anxiety, inattention), cognitive (e.g., memory
deficits, delayed language acquisition), and metabolic problems. Despite opioid use being linked to adverse
maternal, fetal, and child outcomes, the mechanisms through which these arise and the potential consequences
of prenatal opioid exposure for child health and development (e.g., brain and behavior) remain largely
unexplored. This lack of etiologic knowledge has contributed to stagnant treatment, prevention, and mitigation
efforts leaving individuals and families susceptible to reverberating adverse outcomes.
The HEALthy Brain and Child Development (HBCD) Study is a 25-site longitudinal prospective study of
early child development in the US that will assess a broad spectrum of biological (e.g., neuroimaging, genetics,
epigenetics), behavioral (e.g., cognition and emotional regulation), experiential (e.g., trauma), social (e.g.,
racism), and health (e.g., psychopathology) factors among ~7,500 nationally-representative pregnant women
and their children from pregnancy to mid-childhood. A major goal of the HBCD study is to increase understanding
of the potential consequences of prenatal substance exposures. It will be enriched for maternal substance use
during pregnancy (i.e., ~25% of the sample will be using opioids, cannabis, alcohol, and/or tobacco during
pregnancy and 12% of the total sample will be using opioids) and offers a unique opportunity to inform our
understanding of how the adverse consequences associated with opioid use during pregnancy arise. Although
HBCD will be the largest long-term study of early brain and child development outcomes in the US, the core
protocol does not include the collection of delivery biospecimens. This Administrative Supplement in response
to NIDA/ORWH Administrative Supplement Notice of Special Interests: HEAL Initiative: Biospecimen Collection
in Pregnancy (NOT-DA-23-005) proposes to leverage existing infrastructure and expand services provided
through the HBCD Data Coordinating Center (HDCC) to fully support expansion of HBCD biospecimen collection
to include delivery specimens (placenta, cord tissue, cord blood). Delivery samples will be collected from a
representative sample of HBCD study participants across up to 14 sites (and over 2,000 participants across
HBCD sites submitting applications in response to this NOSI). This will provide an unprecedented resource
generating opportunity for the larger scientific community to comprehensively evaluate pathophysiological
mechanisms that mediate the connection between opioid and polysubstance use during pregnancy and adverse
neonatal, infant, and/or maternal health outcomes and, in turn, inform innovative preventive strategies.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement for the Data Coordinating Center responsible for supporting the large, national, longitudinal HEALthy Brain and Child Development Study (HBCD) will provide the requisite state-of-the-art data infrastructure necessary to expand biospecimen collection of the HBCD core protocol to include delivery specimens (i.e., placenta, cord tissue, cord blood). The result will be an unprecedented resource-generating opportunity for the larger scientific community to comprehensively evaluate both the pathophysiological mechanisms that mediate opioid use during pregnancy and the resulting adverse neonatal, infant, and/or maternal health outcomes, critical data which will inform innovative preventive strategies.